A National Neighborhood Data Resource to Understand Inequities in the Health and Socioeconomic Impacts of COVID-19 in the United States

The COVID-19 pandemic has resulted in substantial changes to American neighborhoods in ways that are only
beginning to be elucidated. There has been an excess of permanent business closures, particularly among
small neighborhood businesses most vulnerable to social distancing, such as local barber shops and nail
salons. COVID-19 outbreaks in late September 2021 caused 2,000 neighborhood schools to close for an
average of six days in 39 states. A burgeoning body of research has tried to understand the forces driving
these trends, focusing on infectious disease transmission at the individual level or economic models at the
business level. What is not considered is the context in which these changes are taking place. By context, we
mean the neighborhood community environment that holds the opportunities, restrictions, risks, and flexibility
for post-pandemic growth, including job opportunities in business sectors robust to social distancing;
comprehensive broadband internet access to facilitate telemedicine, online schooling, remote work, and online
grocery shopping; parks and walkable streets to facilitate socially distanced physical activity and social
interaction to mitigate social isolation brought on by the pandemic; and the provision of medical care through
the availability of alternate health care providers and pharmacies. Access to these neighborhood resources is
not equally distributed across America, reinforcing risk for vulnerable populations, including older adults,
children and adolescents, racial/ethnic minorities, and those in rural areas. However, a lack of national,
standardized, longitudinal metrics of the local neighborhood environment has hindered the ability to identify
which communities are most vulnerable to the immediate and longer-term consequences of the pandemic for a
host of behavioral, psychological, social, and economic outcomes. To address this limitation in the nation's
data infrastructure, we will augment, curate and disseminate data from our National Neighborhood Data
Archive (NaNDA), which includes a wealth of physical, social and economic characteristics of the local
neighborhood across the United States (e.g., racial segregation, business density, environmental hazards,
broadband internet access, and healthcare availability), in the years both before and since the pandemic. We
will participate with the Consortium on Social, Behavioral, and Economic Research on COVID-19 to integrate,
share, and analyze spatially referenced neighborhood data that can be readily linked to existing survey data,
cohort studies, or electronic health records at various levels of geography. We will work with the COVID-19
Consortium Coordination Center to identify and create key neighborhood metrics that are priorities for research
teams in the Consortium, including a set of common data elements (CDEs) on the social, behavioral and
economic indicators of the COVID-19 pandemic at the neighborhood level. We will also develop new metrics of
longitudinal neighborhood change in the decades preceding the pandemic, which can inform community risk
and resilience since the pandemic.

Public health relevance
PROJECT NARRATIVE The consequences of the COVID-19 pandemic have been unequally felt by individuals and communities across the United States. To understand these patterns, we will create, integrate, and share data on neighborhood characteristics, both before and since the pandemic, that can be readily linked to existing survey or cohort studies at various levels of geography. This national neighborhood data resource will support the scientific community in understanding the mechanisms that may convey risk and resilience, particularly in underserved and vulnerable populations, and will allow us to more effectively prepare for the next public health emergency.